Investigating BMAL1-RNA interactions and their roles in circadian rhythms

PROJECT SUMMARY
The circadian clock is an endogenous timekeeping mechanism that drives daily rhythms in gene expression,
physiology, and behavior. The key components of the circadian clock in mammals are transcription factors and
regulators that drive rhythmic transcription. Recently, RNA has emerged as a biophysical modulator of
transcription factors and other chromatin-associated factors via direct interactions. However, how these RNA-
protein interactions might shape circadian rhythms remains unexplored. My preliminary data suggests that a
master circadian transcription factor BMAL1 directly interacts with RNA. This led to the hypothesis that BMAL1-
RNA interactions modulate circadian rhythms. To test this hypothesis, I propose the following aims: (1) Identify
and characterize BMAL1-binding RNAs, (2) Define structural determinants of BMAL1-RNA interaction and
determine their role in regulating circadian transcription and translation. I will carry out this study using a variety
of molecular biology and genomic techniques, including a biochemical assay to capture RNA-protein
interactions, RNA sequencing, and genetic manipulation. This work will uncover a novel modulatory
mechanism of circadian rhythms and provide a foundation for studying the mechanistic link between the
circadian clock and a wide range of RNA-mediated cellular functions. This fellowship will provide an excellent
opportunity to gain expertise in molecular biology and RNA-protein interaction. This will prepare me to become
an independent academic investigator studying circadian rhythms at multiple levels.

Public health relevance
PROJECT NARRATIVE The proposed research will open the exciting possibility that BMAL1-binding RNAs could lead to circadian RNA therapeutics to improve circadian health and reduce the risk of many diseases, including sleep disorders, metabolic disorders, and cancer. Dysregulation of circadian rhythms and RNA biology is concomitantly found in many neurobiological diseases, including amyotrophic lateral sclerosis, Alzheimer's disease, and autism spectrum disorder. The proposed research addresses the intersection between circadian and RNA biology, thus offering a unique opportunity to address this concomitant disruption.